Charting the role of variability in learning across development

Project Summary/Abstract
The way individuals learn from their environment reliably changes with age and experience. A common
pattern observed across a wide range of cognitive tasks is that younger children tend to exhibit greater
variability in accuracy, reaction time, and other general response patterns, and this variability decreases both
within and between subjects with increasing age. While this increased variability is widely acknowledged as a
feature of development, the neural and computational processes underlying such variability remain to be
discovered, and its potential functions for learning remain poorly characterized. The goal of this research
proposal is to chart behavioral and neural variability associated with changes and improvements in learning
across development. To accomplish this goal, we will apply computational modeling and neuroimaging
methods to better discriminate patterns of variability observed in children during learning, and the variability
reduction process that takes place with maturation. We will explore two key measures of variability: (1) the
process of exploration of choices during learning, and (2) the development of strategies used to test
hypotheses about the regularities of the information to be learned. Comparing a continuous sample of children
through adults, we will test three core predictions. First, in Aim 1 we predict that children will show greater
variability in the form of greater exploration and choice stochasticity in an explore-exploit reinforcement
learning task, and this pattern of exploration will decrease with age. Second, in Aim 2 we hypothesize that
when forming strategies in order to learn how to best classify stimuli in a simple perceptual categorization task,
children will demonstrate greater variability by using a random guessing strategy for a longer duration and
switching between strategies more often than adults. Third, we hypothesize that these behavioral effects will
be modulated by late maturing prefrontal cortical regions - the frontopolar cortex during exploration, and medial
prefrontal cortex during strategy formation – and the degree of activation in these regions will increase in
magnitude with age. No previous study has simultaneously examined both the behavioral and neural
processes underlying exploration and strategy use during learning across development. As such, we hope to
gain a more detailed and nuanced understanding of how precise measures of variability can elucidate
developmental differences in the way we learn. By better clarifying the process of variability reduction in
learning during development, this research may inform future translational work in identifying when and how
the cognitive development of a child or adolescent may not be following a normative trajectory. This knowledge
can aid in designing better early diagnostic measures for individuals at risk of developing learning disabilities or
neurodevelopmental disorders associated with greater neural and behavioral variability such as ADHD and
autism.

Public health relevance
Project Narrative This work aims to characterize the behavioral and neural variability associated with changes and improvements in learning across development. By more precisely delineating the normative trajectory of variability reduction with age and experience during learning, these findings can help identify atypical developmental patterns, and aid in early detection of learning disabilities or neurodevelopmental disorders associated with greater variability, such as autism and ADHD.